Discovering Novel Drug Targets for CNS Edema by In Vitro Genetics

Abstract: Brain swelling is a serious complication of traumatic brain injury (TBI), ischemic stroke and other serious conditions. TBI and stroke afflict 1.4M and 700K persons per year in the US alone. They are a costly health care burden and a devastating social burden. Current treatments for brain swelling are limited and generally ineffective, highlighting the dramatic unmet need for better therapeutics. A better understanding of the molecular pathways and cellular mechanisms is sorely needed to identify new drug targets and predictive biomarkers that can stratify patients for clinical treatment decisions. The goal of this project is to identify new drug targets and biomarkers of response for cytotoxic edema of astrocytes. We will use a novel and innovative technology that we have developed that takes an unbiased approach to functionally identifying the causal mediators of brain cell swelling. Our approach uses a large panel of genetically diverse astrocyte lines to identify the genes and pathways that mechanistically underlie cytotoxic edema. In Phase I, we developed a high throughput kinetic assay for astrocyte swelling that is robust and scalable for screening compounds that induce or block swelling. In Phase II we will screen 300 genetically diverse astrocyte cell lines and then map and identify the genes that mediate response to inducers and blockers of cell swelling. Validation of candidate target genes will be conducted in both human and mouse astrocytes. Human genes that modify human astrocyte response that are also therapeutically accessible target genes for novel drug discovery are the ultimate aims and products of this project.

Public health relevance
Brain swelling (cerebral edema) is a serious consequence of many disorders such as traumatic brain injury and stroke. A more complete understanding of the molecular pathways underlying cerebral edema is a critical bottleneck in the development of new drugs for brain swelling. We want to understand the molecular mechanisms underlying swelling in astrocytes, the most abundant cell type in the brain, toward the discovery of more effective treatments for brain edema. !